Complex III-derived reactive oxygen species in mitochondrial-nuclear crosstalk in Alzheimer's disease and related dementias

SUMMARY
Alzheimer's disease (AD) and related dementias involve multifactorial and interconnected mechanisms,
including APP/amyloid-β (Aβ) pathology, tauopathy, neuroimmune responses, neuronal impairments, and glial
alterations. Mitochondrial dysfunction is an early event influenced by various disease-related factors, including
Aβ and apolipoprotein E4 (APOE4), the strongest genetic risk factor for late-onset AD. Mitochondria produce
energy, but are also a major source of reactive oxygen species (ROS). Mitochondrial ROS (mtROS) increase in
aging and disease, are associated with pathogenic processes, including protein misfolding, synaptic deficits, and
neuroinflammation, and can diffuse to other subcellular compartments to signal and influence metabolic, redox
and health status. Complex III (CIII) of the mitochondrial respiratory chain has the largest capacity for ROS
production and can release ROS toward the intermembrane space and extra-mitochondrial compartments, thus
poising CIII-derived ROS (CIII-ROS) to affect signaling pathways and nuclear functions. However, the
mechanisms by which CIII-ROS may influence nuclear processes and affect AD pathogenesis are not defined.
Astrocytes are reported to produce high levels of mtROS. Thus, we examined the regulation and roles of
astrocytic mtROS using live-cell redox imaging, site-selective mtROS suppressors, targeted genetic
manipulations, molecular profiling, and preclinical testing, among other approaches. Our findings reveal that
disease-linked factors, including Aβ, induce astrocytic CIII-ROS in a temporally defined and NF-κB-dependent
manner. Induction of CIII-ROS caused selective oxidation of target proteins and amplified STAT3 activation and
gene expression changes linked to astrocytic reactivity and disease responses. Suppression of CIII-ROS
decreased brain pathology and neuroimmune responses, and extended lifespan in mice with tauopathy. Notably,
APOE is highly enriched in astrocytes and influences mtROS levels. Our data suggest that the APOE4 variant
exacerbates astrocytic mtROS responses whereas the AD-resilience variant of APOE (R136S Christchurch)
inhibits these responses. However, the exact effects of APOE variants on astrocytic mtROS dynamics and the
roles of mtROS in gene regulation and dementia risk are not clear. In the current project, we will examine the
underlying mechanisms and effects of astrocytic mtROS-nuclear crosstalk in neural cultures and knock-in mouse
models. We will define mtROS responses and their regulation and roles using cutting-edge live-cell imaging,
multiomic profiling, functional measures, and other complementary methods. Together, our study will leverage
advanced model systems and technologies to identify new molecular networks mediating mitochondrial-nuclear
crosstalk and reveal novel redox-linked therapeutic strategies for AD and related neurodegenerative disorders.

Public health relevance
PROJECT NARRATIVE Mitochondria produce free radicals which may contribute to neurodegenerative disease, but exact effects and mechanisms are not defined. We will determine the roles of mitochondrial free radicals in protein modifications, gene regulation, and related molecular changes. This project will establish bidirectional signaling pathways between mitochondria and nuclear functions in Alzheimer's disease and related dementias.